Elucidating the Interplay of Genes and Environment in Autism Using Genomic and Exposure Data from Large Populations

Elucidating the Interplay of Genes and Environment in Autism Using Genomic and Exposure Data
from Large Populations
Abstract
Autism spectrum disorder (ASD) is a multifactorial neurodevelopmental condition influenced by both
genetic and environmental factors. While rare and common genetic variants have identified over 100
ASD-associated genes and copy number variants (CNVs), the mechanisms through which environmental
exposures modify genetic susceptibility remain poorly understood. A major barrier to progress has been
insufficient sample size to rigorously investigate gene-environment interactions (G×E). To address this
gap, we have assembled a combined dataset of 2.7 million individuals with paired genetic, environmental,
and clinical data across multiple cohorts. This study will apply innovative causal inference frameworks to
disentangle direct environmental effects from gene-environment correlation, identify genetic modifiers of
environmental exposures, and develop predictive models integrating genetic, environmental, and clinical
data. In Aim 1, we will investigate prenatal exposures and early-life environmental factors in two deeply
phenotyped cohorts (ABCD, HBCD) with genome-wide genetic data, neurodevelopmental assessments,
neuroimaging, and EEG. In Aim 2, we will examine G×E effects in neonatal intensive care using whole
genome sequencing and perinatal electronic health record (EHR) data from the BeginNGS consortium. In
Aim 3, we will conduct large-scale meta-analyses of these studies with biobanks (Regeneron, UK
Biobank, All of Us, Estonian Biobank) and the SPARK ASD family cohort to identify G×E interactions, and
to elucidate causal pathways through which environmental exposures contribute to ASD. The proposed
study will generate novel insights into modifiable environmental risk factors and their interaction with
genetic susceptibility to ASD, providing a foundation for targeted prevention and personalized intervention
strategies.